North American AIDS Cohorts on Collaboration and Design (NAACCORD)

The North American AIDS Cohort Collaboration on Research and Design (NA-ACCORD) has
represented Region 1 of the leDEA initiative since 2006. The 23 single and multi-site clinical and
classical epidemiologic HIV cohorts of the NA-ACCORD encompass most HIV cohorts within the
US and Canada. Over 100 sites contribute data collected from over 190,000 people with HIV
(PWH). We have established a strong collaborative infrastructure that capitalizes on the talents
and expertise of a multi-disciplinary group of investigators that span basic science, clinical
research, epidemiology, data informatics and biostatistics. We have been highly productive in
addressing our previous Aims and key questions in contemporary care and public health relevant
to adult PWH. Our strengths are especially relevant to the goals of the US DHHS Ending the HIV
Epidemic (EHE) initiative, uniquely providing the broad geographic and demographic scope,
established scientific platform, large sample size, extensive longitudinal follow-up of >1.3 million
person-years, and depth of clinical data to inform the goals of EHE with rich data on those who will
continue to survive with HIV after transmission is halted. With the onset of the COVID-19
pandemic, questions regarding the impact of COVID-19 on HIV outcomes and trends in HIV
indicators, as well as longer-term outcomes of COVID-19 among PWH, can be answered in the
NA-ACCORD. Within this context, we present three broadly-defined aims for the next funding
cycle: Aim 1: Characterize the longitudinal course of HIV treatment, progression and outcomes in
North America in the setting of the EHE initiative, which will increase the number and heterogeneity
of those in HIV care as HIV treatment and the long-term challenges of living with HIV continue to
evolve. Aim 2: To assess and characterize the clinical course of HIV infection in North America,
with a focus on major non-AIDS comorbidities and co-infections, multimorbidity and comorbidity-
free life expectancy. Aim 3: To expand and extend our state-of-the art epidemiologic, biostatistical,
and data science methodologic approaches. The NA-ACCORD is a world-class collaboration of
established HIV cohorts well-positioned to a) provide in-depth understanding of the longitudinal
course of HIV when extraordinary efforts are being made to EHE; b) collaborate with the other
IeDEA regions to inform the future HIV epidemics in low- and middle-income regions; and c)
understand differences in HIV treatment, outcomes and prognostic factors that will inform future
research and HIV care globally.

Public health relevance
The NA-ACCORD is the most wide-ranging and in-depth collaboration of HIV cohorts that exists within North America. Its large sample size, the comprehensiveness and quality of its data, combined with the expert use of state-of-the-art statistical methods will allow us to provide answers to the most pressing questions of contemporary importance for the care and outcomes of people with HIV in the US and Canada. The questions will inform the End the HIV Epidemic initiative and provide important information on the long-term course of HIV disease.